Patterns of Aging and the Role of Biomarkers of Senescence

ABSTRACT
Over the past century, life expectancy has increased by 30 years. With that gain has come a dramatic rise in
age-related disease and an urgent need to understand, prevent, and treat these conditions. While age-related
diseases have diverse phenotypes, there is increasing recognition of common biological underpinnings with
cellular senescence as the nexus linking subcellular changes due to epigenetic changes, DNA damage, and
mitochondria dysfunction with a decline in health due to multi-morbidity.
To begin unveiling the mechanism underlying senescence dynamics over the span of human life, this project
brings together an interdisciplinary team of experts in mathematical modeling, the biology of aging, and clinical
research. Specifically, the first aim of this integrative project is to determine if the p16INK4a mRNA – a biomarker
of aging and cellular senescence – measured in T-cells reflects total senescence load at the systems level. The
next goal is to determine how senescence dynamics is affected by age-associated diseases. Finally, the team
will test the ability of their computational models of senescence at the cellular and organismal levels to predict
donors’ multi-morbidity status, establishing the link between senescence and clinical and functional decline.
To achieve these objectives, the researchers will measure p16 mRNA levels in donors over the adult lifespan
using an optimized, analytically validated, clinical-grade p16 assay. In parallel, they will develop a computational
stochastic model of p16 levels in T-cells taking into account age-dependent modulation of the regeneration and
attrition rates. The results of this p16-T-cell modeling will be compared with the computational whole-body-p16
model and the data from a p16-luciferase mouse model. The models of p16 expression will also be apply to
compare the expression profiles and the underlying parameters for the healthy donor data and the data from
cancer and heart disease patients. Then, the team will perform a correlation analysis of senescence and donors’
health to determine whether p16 expression predicts dysfunction more readily in some organ systems vs. others,
potentially reflecting differential susceptibility to senescence-associated disease.
This project will make a significant contribution to understanding the phenomenon of senescence, its regulation
and dynamics, and its role in physiological or pathological processes during human aging. These findings will
serve as pilot data for an R01 application to expand p16 analysis to other cohorts and begin to establish
comparisons between p16 and other potentially clinically relevant aging biomarkers such as DNA methylation
panels and plasma proteomics panels.

Public health relevance
NARRATIVE Senescence is a state of permanent cellular growth arrest, when cells cannot divide, do not contribute to tissue repair and homeostasis, but remain metabolically active and secrete pro-inflammatory cytokines and matrix proteases causing tissue inflammation, impaired regeneration, and, ultimately, aging. Over the last fifteen years, the cell cycle inhibitor p16INK4a has emerged as a marker of cellular senescence and a promising indicator of individuals at risk for age-related diseases and adverse events associated with their treatments. In this project, we integrate experimental measurements of p16INK4a expression and mathematical modeling to elucidate the dynamics of senescent cell accumulation in humans over the adult lifespan and the ability of such measurements to stratify subjects by clinical, functional, and mental performance.